In vivo and ex vivo gene editing for Artemis-deficient SCID

Primary Immune Deficiencies (PID) are a heterogeneous class of diseases ascribed to individuals exhibiting
deficiency or severe impairment of cellular and/or humoral immunity. This proposal focuses on a form of PID
associated with radiation sensitivity and defects in V(D)J rearrangement caused by mutations in the DCLRE1C
(Artemis) gene, “ART-SCID”. Artemis is a hairpin-opening enzyme that plays an essential role in V(D)J
recombination, immunoglobulin and T cell receptor gene rearrangement in immunodevelopment. The only
effective therapy for ART-SCID is allogeneic hematopoietic stem cell transplant (HSCT), for which there is a
significant risk of morbidity and mortality. Our team demonstrated that ex vivo lentiviral correction of Artemis
deficiency in a mouse model of SCID-A was most effectively accomplished using the endogenous Artemis
promoter to regulate expression, forming the basis for our teams’ clinical trial initiated in 2018 (NCT03538899).
However, results from clinical trials using viral vectors have highlighted some of the limitations of genomically
dispersed vector-mediated integration, such as genotoxicity associated with insertional oncogene activation,
genomic instability, transgene silencing, and disrupted proliferative control. What we envision in this
proposal is the next generation of genetic therapies for Art-SCID by chromosomal site-directed
correction of the endogenous Artemis gene in hematopoietic stem cells. The Specific Aims of this
proposal address key questions in the development of a targeted genetic approach for therapy of ART-SCID
and PID in general: Aim 1: What is the feasibility of targeted modification of the Artemis locus at a single
genetic lesion for restoration of immune function? To address this question, we have developed an Adenosine
Base Editing (ABE) approach that functionally restores a TAA nonsense mutation in the Artemis gene that is
prevalent in Navajo and Apache Native Americans. We have also established a new mouse strain transgenic
for the human TAA nonsense mutation (SCID-A mice). Using electroporation conditions that we have shown to
be effective for introduction of CRISPR gene editing reagents, in Aim 1 we will deliver ABE along with guide
RNA targeting the Artemis TAA stop codon in mouse hematopoietic stem cells transplanted into recipient
SCID-A mice, evaluating the animals for restored immunity. Aim 2: How can targeted genetic modification be
extended from ex vivo to in vivo delivery of CRISPR reagents targeting the Artemis gene? In Aim 2 we will test
adenovirus vectors and AAV vectors targeted to hematopoietic stem cells for in vivo delivery of ABE and
restoration of immunity in SCID-A mice. Results from these studies will have immediate implications for
genetic therapy of ART-SCID and by extension for therapy of PID in general.

Public health relevance
Project Narrative Primary immune deficiencies are a rare group of inherited diseases caused by genetic deficiency in patients who suffer from the inability to fight off common infections. In this grant application we are working to repair the defective gene in the patients’ blood cells, thereby restoring the ability of the patient to fight infections. The specific research proposed in this application will first test the procedure by correcting the cells outside of the body, and then will test a procedure for correcting the cells without having to remove them from the body.